Measurement of cognition and functional decline in Latinx older adults for detection of Alzheimer’s Disease and Related Dementias: A mixed-methods approach

Accurate and valid measurement of cognitive and functional decline for the detection of Alzheimer’s Disease and
Related Dementias (AD/ADRD) in Latino/a/x older adults is a critical public health priority. The Latinx population is
rapidly growing and aging in the U.S. with enormous expected growth of AD/ADRD in older Latinx adults in the coming
years. It is unknown whether cognitive assessment instruments measure cognitive health with equal precision and
validity across Latinx and non-Latinx white (NLW) older adults, which is a critical barrier to the accurate detection of
AD/ADRD, its determinants, and its impact. This study will use a mixed-methods approach to evaluate the validity and
equivalence of measures of cognitive and functional decline in Latinx and NLW older adults, using the Harmonized
Cognitive Assessment Protocol (HCAP) cognitive test battery (HCAP-R) and informant ratings of cognitive and functional
decline (HCAP-I). Specific Aim 1 will examine the extent to which the HCAP-R and HCAP-I exhibit statistical evidence of
measurement bias across years of education, assessment language (English/Spanish), and ethnicity (Latinx/NLW), using a
series of psychometric analyses. Data from the Health and Retirement Study (HRS)-HCAP study will be combined with
data from the Brain Attack Surveillance in Corpus Christi (BASIC)-Cognitive study for this analysis. Specific Aim 2 will
utilize longitudinal data from the BASIC-Cognitive study to examine whether the HCAP-R is equally predictive of
longitudinal trajectories of informant-rated cognitive and functional decline (HCAP-I) between Latinx and NLW older
adults and whether adjustment for statistical measurement bias eliminates any differences in this predictive
equivalence. Specific Aim 3 will perform new data collection using a qualitative methodology (cognitive interviewing) to
examine the linguistic and cultural validity of HCAP-R and HCAP-I items in a sample of Mexican American older adults
with varying levels of education and Spanish language use. These data will provide a novel integration of mixed methods
(psychometric, longitudinal prediction of cognitive and functional decline, and qualitative) to inform the equivalence and
validity of the HCAP across culturally, linguistically, and educationally diverse older adults. This K23 program will provide
PI Dr. Briceño with training to develop expertise in psychometric and longitudinal data analysis, qualitative research,
population-based cognitive aging and health disparities research, and research leadership. Training will occur through
individual mentoring, formal workshops and seminars, and international conferences. The K23 mentors are international
leaders in Latinx brain health equity, psychometrics, population-based cognitive aging, and cross-cultural
neuropsychological assessment of AD/ADRD. The K23 will provide Dr. Briceño with expertise and preliminary data to
submit an R01 and to become an independent researcher in cognitive health disparities in AD/ADRD. The University of
Michigan provides an ideal environment to conduct the proposed research and career development, with abundant
resources, facilities, training opportunities, and collaboration.

Public health relevance
The proposed project will address an urgent public health need to optimize the accuracy and validity in measuring cognitive decline due to AD/ADRD in the rapidly growing and aging Latino/a/x older adult population. The proposal will investigate whether available tools for the assessment of cognitive impairment due to AD/ADRD measure cognitive and functional decline equivalently in Latino/a/x compared to non-Latinx white older adults. This research will lead to more accurate estimates of the prevalence, determinants, and impact of AD/ADRD in Latino/a/x older adults.